Behavioral, Neural, and Molecular Correlates of Response Inhibition in Bipolar Disorder

PROJECT SUMMARY
Difficulty with inhibitory control, which contributes to impulsive behavior, is a core feature of bipolar disorder (BD)
and persists across mood states. Response inhibition (RI), an aspect of behavioral inhibition, is classified as a
subconstruct under the domain of cognitive systems within the Research Domain Criteria (RDoC) framework.
Although impaired RI has been observed in BD, there is still a limited understanding of this aspect of inhibitory
control, and it has not been translated into treatment options in the clinic to date. Elucidating the role of impaired
RI and its underlying neurobiology in BD is critical for identifying novel targets for interventions to reduce
impulsivity and related risky behaviors.
The proposed study will focus on understanding the behavioral, neural and inflammatory measures of RI in BD
and employ an interdisciplinary approach to 1) characterize RI using self-report and performance based
measures (Training goal 1); 2) characterize the neural circuitry underlying RI by measuring a) brain activation
patterns, while performing the Parametric Go/No-Go Test (PGNG), and b) resting-state functional connectivity of
cognitive control network (Training goal 2); 3) examine the association of peripheral inflammation (i.e., CRP, IL-
6, TNF-α) with behavioral and circuit-based processes that underlie RI (Training goal 3), and 4) examine the
association of central inflammation (extracellular free water [FW]) with both peripheral inflammation and RI
(Training goal 3). We will enroll 100 affectively stable BD patients and 50 demographically matched controls.
Subjects will complete the Stop Signal Test (SST) and the PGNG outside the scanner. Inflammatory markers in
blood and FW levels in the brain will be quantified. Fifty BD patients and 50 controls will undergo resting-state
and task-based functional magnetic resonance imaging (fMRI), and diffusion-weighted MRI (DWI-FW).
This Mentored Research Scientist Development Plan aims to assist the candidate in achieving the following
goals: 1. To receive specialized training in neurocognitive testing, with a focus on inhibitory control, and gain
experience in clinical symptomatology and research considerations in patients with BD, 2. To gain theoretical
and applied knowledge in the collection and interpretation of brain-based measures, with a specific focus on the
cognitive control network, 3. To expand knowledge in psychoneuroimmunology within the context of mental
health research by integrating peripheral inflammation and a proxy measure of neuroinflammation.
Training activities aligned with the proposed project will include formal coursework, hands-on training, directed
readings, workshops, grant writing, and research activities. This project and related training activities will primarily
take place at Brigham and Women's Hospital, Harvard Medical School. This proposed research study and
training plan will prepare the candidate to become an independent scientist establishing a research program that
integrates biological, behavioral and cognitive measures to identify biobehavioral mechanisms that inform
intervention development, reduce disease burden and promote the quality of life of patients with mood disorders.

Public health relevance
PROJECT NARRATIVE Difficulty with inhibitory control, which contributes to impulsive behavior, is a hallmark feature of bipolar disorder (BD), with significant health and societal impacts. This study seeks to understand brain (neuronal circuits, neuroinflammation) and blood (peripheral inflammation) markers associated with impaired inhibitory control in BD, which may inform key targets for novel interventions to reduce impulsive behavior and associated negative outcomes in BD.